Discovery of novel protein complexes across human gut bacteria

Following my recent arrival at the National Cancer Institute, Center for Cancer Research, I am currently in the process of establishing my lab within the Center for Structural Biology. This includes acquiring key reagents and the necessary equipment and technology for carrying out my research and completing the required training. I am also taking steps to recruit several postdoctoral fellows. I await several key pieces of equipment including the installation of the mass spectrometer, chromatography systems and anaerobic chamber. I anticipate initiating research studies before the end of the fiscal year.